Borrelia burgdorferi mitogen in development of arthritis

Project Summary/Abstract
Lyme disease, caused by the tick transmitted pathogen Borrelia burgdorferi, is estimated to be responsible for
300,000 new cases per year in the United States. Disease manifestations include a skin lesion at the site of
the tick bite, followed by disseminated symptoms including secondary skin lesions, arthritis, Bell’s palsy,
peripheral neuropathies, meningitis/encephalitis, and carditis. Most individuals respond to antibiotic treatment,
particularly if started early in infection, however, up to 20% of patients experience a delay in the return to
normal health. This persistence of symptoms following antibiotic treatment is termed post treatment Lyme
disease symptoms, PTLDS, and encompasses disseminated symptoms including neurological abnormalities,
fatigue, and arthritis. The underlying mechanism of sustained symptoms is not understood and is an area of
active investigation. Hypotheses include presence of persister spirochetes, presence of pro-inflammatory
bacterial fragments, dysregulation of anti-inflammatory processes, and emergence of auto-reactive B and T
lymphocytes. The lack of easily manipulated animal model has limited understanding of chronic disease.
Using the IL-10 deficient mouse as a model for joint disease that persists following immune-mediated
clearance of B. burgdorferi, we have identified bystander activation of T lymphocytes that drive IFN
dependent arthritis. Bystander activation of T cells is independent of classic MHC-TCR engagement, but
dependent on T cell intrinsic expression of TLR2. We have also found that patients with PTLDS have elevated
numbers of activated CD4+ and CD8+ T cells in their peripheral blood, when compared with patients who return
to normal health. We will expand molecular characterization of bystander-activated T cells in mice and
patients in order to identify novel targets for therapeutic intervention. These will be tested in the IL-10-/- model
of chronic Lyme disease. Preliminary studies indicate short-term targeting of TLR2 is potential therapeutic for
Lyme arthritis. The overall goal of study is to identify novel treatments for chronic Lyme disease that target
inappropriately activated T cells without compromising host defense.

Public health relevance
Project Narrative A small percentage of patients infected with the Lyme disease pathogen Borrelia burgdorferi develop symptoms that persist following antibiotic treatment, termed post treatment Lyme disease syndrome, PTLDS. We have developed a mouse model of PTLDS and found that bystander activated T cells drive sustained symptoms of disease and display a novel gene expression signature. We will use this mouse model to test potential treatments for PTLDS. Identification of targeted therapeutics could result in new treatments for PTLDS patients.